Diabetes and Aging in a Multi-Ethnic Population

DESCRIPTION (provided by applicant): Over 40 percent of patients living with diabetes are over 65 years of age, yet very little is known about the risks and benefits of diabetes care in an aging population. This vulnerable population is more heterogeneous than younger patients in terms of functional status, comorbidities and life expectancy, and may need more individualized management of glucose, blood pressure, and cholesterol levels. The special concern that motivates this study (especially since excess deaths led to the discontinuation of the intensive glucose-lowering arm in the ACCORD trial) is the possibility that the risks or burden of intensive and comprehensive diabetes care may outweigh the benefits for some older patients. Geriatric diabetes care guidelines currently recommend that providers consider 5-year life expectancy, risks of hypoglycemia, and geriatric syndromes (e.g., falls, cognitive decline) when setting diabetes treatment goals. While these new recommendations have a clinical rationale, they have not been formally evaluated with data from contemporary epidemiological studies, they lack validated prognostic tools for risk-stratification (predictive 5-year survival models), and their policy implications for quality assessment and health disparities have not been explored. Moreover, little is known about ethnic differences in the natural history of diabetes and their effect on care and outcomes in the elderly. We propose a prospective (2005-2014) examination of a large contemporary, multi-ethnic cohort of ~112,000 older (e60 years of age) diabetes patients identified from the Kaiser Permanente Northern California Diabetes Registry, and sub-studies in a cohort of survey responders (N=9,763). We will: i) characterize the current state of diabetes care management by health status, evaluate quality of life, and estimate rates of traditional complications, hypoglycemia, geriatric syndromes and mortality;ii) describe the interrelationships of hypoglycemia and geriatric syndromes;iii) evaluate the effects of antihyperglycemic therapies and polypharmacy on hypoglycemia, geriatric syndromes, and mortality;iv) create a generalized prediction model for 5-year, all-cause mortality and evaluate the performance of existing prognostic mortality prediction models;and v) explore the health policy implications of the widespread adoption of geriatric diabetes guidelines. This multi-institution, prospective study will expand our understanding of the dynamics of health care and outcomes among elderly diabetes patients. Study findings will provide important insight into the validity and implications of geriatric guidelines, and help ensure that quality improvement efforts for geriatric diabetes care are not at odds with efforts to improve diabetes outcomes and will not increase health disparities within health systems.

Public health relevance
Public Health Relevance: Over 40 percent of patients living with diabetes are over 65 years of age, yet very little is known about the risks and benefits of diabetes care in an aging population. This vulnerable population is more heterogeneous than younger patients in terms of functional status, comorbidities and life expectancy, and may need more individualized management of glucose control. The special concern that motivates this study is the possibility that the risks or burden of intensive and comprehensive diabetes care may outweigh the benefits for some older patients. There are now specific recommendations for individualizing diabetes care in the elderly; these include focusing on the prevention/management of common geriatric syndromes and reducing the intensity of glucose control in patients with less than a five year life expectancy. While these new recommendations represent a major conceptual advance in diabetes care, there is little contemporary evidence to support these recommendations. Moreover, little is known about ethnic differences in the natural history of diabetes and their effect on care and outcomes in the elderly. We propose to redress these deficiencies in clinical knowledge. Study aims include: i) characterizing the current state of diabetes care management by health status, quality of life, and rates of traditional complications, hypoglycemia, and geriatric syndromes; ii) describing the interrelationships among hypoglycemia and the various geriatric syndromes; iii) evaluating the effects of antihyperglycemic therapies and polypharmacy on hypoglycemia, geriatric syndromes, and mortality; iv) creating a generalized prediction model for 5-year, all-cause mortality and evaluate its performance relative to existing prognostic mortality prediction models; and v) exploring how, following guideline-based recommendations, observed ethnic differences in baseline health status and life expectancy may result in different levels of care intensity across ethnic groups. The findings of this study will have important implications for the growing population of older patients with diabetes, where the aggressive pursuit of intensive diabetes care can be at odds with quality of life considerations. Finally, the widespread adoption of geriatric diabetes care guidelines within healthcare systems must be done with consideration of our parallel goal of also reducing heath disparities among the elderly.